Computer Core

Summary/Abstract
The role of the Computer Core is to provide specialized computer services to vision scientists throughout
Columbia University, with priority given to investigators supported by NEI RO1 grants. Computer technology is
critical to all modern visual science: database management, genetic and neuroscientific computation, reliable
data storage, and serving as on-line adjuncts to laboratory instruments, and the Core facilitates all of these
processes. The Core has 2 major components: 1) the Harkness Eye Institute (HEI) site, which includes: A. The
Genomics Analysis Suite, B. The databases and server center, C. Computing and programming services; and
2) the Zuckerman Mind, Brain, and Behavior Institute (ZMBBI), where the Core provides real-time software and
hardware components for visual systems neuroscience.
Although the University provides standard PC backup (e.g. support for Windows and Microsoft Office),
visual systems neuroscience requires much more sophisticated support. In systems neuroscience rather than
performing an isolated data analysis function, computers are integrated into the experimental apparatus itself,
performing a number of functions in real time, such as controlling the animal’s behavior, measuring eye
movement and arm movement, collecting single neuron activity, and doing preliminary data analysis. This
requires special real-time operating systems, usually beyond the ability of the University PC technicians, and
special interfaces to enable an efficient interface between the experimental apparatus and the computer.
Because the Zuckerman Institute now provides server and off-site backup facilities, this frees up the Core for
more creative computer interface development, for example to facilitate the new development of multiple single
neuron recording, including the adaptation of high speed graphics cards to physiological recording, areas beyond
the expertise of the ZMBBI computer team. The Core will also provide emergency computer backup when the
ZMBBI team is unavailable.
The Harkness Eye Institute is heavily reliant on SQL databases and programming, again a capability
beyond that of the University computer technicians. The new component of the Computer core at the HEI is the
innovative Genomics Analysis Suite, which will provide integrated data management and analysis capabilities
for genetic and imaging data. The Core will also foster collaborations among the group of visual systems
investigators themselves, and also between experimental vision scientists and computational neuroscientists at
the ZMBBI’s Center for Theoretical Neuroscience. At HEI it will enable a number of collaborations between
vision scientists and scientists new to vision research.